Validation of Imaging and Blood-based Small Vessel VCID Biomarkers in Multiethnic Population

PROJECT SUMMARY/ABSTRACT
The MarkVCID consortium was established in 2016 to pursue the initial stages of multi-site validation of 7
imaging-based and 4 fluid-based candidate biomarkers for small vessel vascular contributions to cognitive
impairment and dementia (VCID). As one of the 7 participating sites, our team at the University of Southern
California (USC) has analyzed and optimized candidate VCID biomarkers during the UH2 phase (years 1-2),
and participated in the consortium-wide program of biomarker scaling-up, multi-site protocol implementation,
and initial multi-site validation during the UH3 phase (years 3-5). USC has led the consortium wide
development and implementation of the optical coherence tomography angiography (OCTA) biomarker kit
which is based on an FDA approved device that allows in vivo and completely noninvasive imaging of retinal
capillaries with a spatial resolution of ~10 microns. We have also participated in the validation of the other 6
MRI based candidate biomarkers, while contributing blood samples for the validation of the 3 plasma-based
candidate biomarkers. The primary objective of the next 5 years is to carry out comprehensive multi-site clinical
validation of candidate VCID biomarkers in longitudinal studies of diverse populations that are typical in clinical
settings in the US. Capitalizing on the high racial diversity in Los Angeles, we plan to enroll a multiethnic
longitudinal cohort of at least 200 subjects that are enriched for small vessel VCID, including 100 Latinx
subjects from the Los Angeles Latino Eye Study (LALES), 50 African Americans (AAs) enrolled in the African
American Eye Disease Study (AFEDS), and 50 Caucasian participants from the Clinical Core of the USC
ADRC. We have performed pilot studies in both Latinx and AA subjects (two largest minority groups in the US)
using MarkVCID protocols to show the feasibility for conducting such studies in a multiethnic cohort. We have
also built a multiethnic team of investigators, technical staff, research coordinators, and community outreach
staff to streamline enrollment, achieve the recruitment milestones and perform longitudinal follow-up studies.
Our team includes established expertise, equipment and infrastructure for OCTA, MRI, fluid biomarker and
clinical/cognitive evaluation of VCID, as well as a proven track record in the sharing of de-identified clinical
data through the Laboratory of Neuro Imaging (LONI) for the second phase of MarkVCID project.

Public health relevance
RELEVANCE TO PUBLIC HEALTH Vascular contributions to cognitive impairment and dementia (VCID) have been recognized as an important cause of clinical dementia. The goal of the MarkVCID consortium, of which the University of Southern California is a participating site, is to be perform rigorous validation of imaging and fluid-based biomarkers for small vessel VCID to be ready for large scale clinical trials to evaluate novel interventions of VCID.